Role of acetyl-CoA in linking cancer cell metabolism and epigenetics

PROJECT SUMMARY
Pancreatic ductal adenocarcinoma (PDA) carries a dismal prognosis, due largely to the fact that it
metastasizes early and is typically detected late, when tumors can no longer be resected. Obesity increases
an individual’s risk of developing PDA, although the mechanisms driving this link are poorly understood. This
proposal investigates the hypothesis that insulin signaling in PDA cells promotes metabolic alterations and
changes in gene expression that facilitate tumor development and progression, potentially pointing towards
new strategies to prevent PDA in at-risk populations or to improve PDA treatment outcomes.
Histone acetylation is highly sensitive to the availability of the acetyl donor acetyl-CoA, and our previous work
has defined a role for the metabolic enzyme ATP-citrate lyase (ACLY) in the regulation of histone acetylation
levels in diverse mammalian cell types. Histone acetylation plays key roles in PDA tumorigenesis, although
the mechanisms that drive altered histone acetylation are not well understood. In preliminary studies, we have
found that insulin and insulin-like growth factor (IGF) stimulation of PDA cells results in ACLY Ser455
phosphorylation, increasing its activity, as well as elevated levels of global histone acetylation. ACLY is
phosphorylated downstream of AKT, and AKT inhibition suppresses histone acetylation globally and at cancer-
relevant loci. We hypothesize that elevated insulin/IGF levels promote metabolic and transcriptional
remodeling in PDA cells, promoting tumor progression. To test this, we will define the role of insulin/IGF
signaling in metabolic and epigenetic remodeling in KRAS mutant PDA cells, using a combination of
hypothesis-driven and unbiased approaches. Finally, we will test the role of ACLY in mediating obesity-linked
pancreatic tumorigenesis, as well as the potential to target acetyl-CoA-dependent processes to suppress tumor
growth and improve therapeutic responses. This study will elucidate new mechanisms through which systemic
metabolism influences cellular metabolism and the tumor epigenome. Findings from this study have potential
to provide a mechanistic rationale for nutritional recommendations for PDA patients and/or to identify new
therapeutic targets to prevent tumor recurrence after surgical resection or to use in conjunction with
chemotherapy to improve its efficacy.

Public health relevance
PROJECT NARRATIVE Obesity is associated with a higher risk of developing pancreatic cancer and worse disease prognosis. Although elevated levels of insulin and insulin-like growth factors contribute to tumor progression and chemotherapeutic resistance, the underlying mechanisms are poorly understood. The metabolic enzyme ATP- citrate lyase (ACLY) is activated in response to insulin signaling and regulates histone acetylation levels in cancer cells, and the proposed study will test the hypothesis that metabolic alterations mediate epigenetic and transcriptional changes to promote tumor progression and may represent targetable vulnerabilities.